Natural killer cells in pulmonary ischemia-reperfusion injury

This is an application for a BLRD CDA-2 award for Dr. Daniel Calabrese, a staff physician at the SFVA and an
Assistant Professor in the Division of Pulmonary and Critical Care at the University of California, San Francisco
who is establishing himself as an investigator in clinical research into the immunology of acute lung injury. This
CDA-2 award will provide Dr. Calabrese with the necessary support to accomplish the following goals: (1) to
improve the understanding of natural killer cells, their receptors, and their ligands in ischemia-reperfusion injury
(2) to acquire theoretical and practical skills in mouse and human immunology and bioinformatics (3) to establish
mechanistic foundations for future interventional trials to improve lung injury syndromes and (4) to establish an
independent basic laboratory scientist career focused on innate immunology in lung disease. To achieve these
goals, Dr. Calabrese has assembled a mentoring team consisting of his primary mentor, Dr. John Greenland, an
international expert in pulmonary immunology and lung injury, and a senior co-mentor Dr. Mary Nakamura, an
expert in the innate immune response to thoracic ischemia-reperfusion injury (IRI). He has assembled a career
development committee and scientific advisory board that will additionally consist of: Dr. Lewis Lanier, an expert
in natural killer (NK) cell biology with over 50 mentees and 250 publications; Dr. Mark Looney, an expert in innate
mechanisms of acute lung injury and mouse models of lung transplantation; and, Dr. Jonathan Singer, director
of the UCSF lung transplant research program and an expert in lung transplant epidemiology research.
Additionally, he will have tutorials and scientific advice from Drs. Jason Christie, Dara Torgerson, Matthew
Spitzer, Michael Matthay, Anatoly Urisman in multi-institutional collaboration, statistical genetics, mass
cytometry, human lung experimental models, and pathology, respectively. The proposed research will expand
on strong preliminary data in two mouse models of lung injury and human samples showing a paradigm-
shifting role for NK cells in ischemia-reperfusion injury (IRI). The proposed study will test the hypothesis
that NK cells directly mediate the lung injury observed in experimental and human ischemia-reperfusion injury
through receptor-specific interactions in the following specific aims: (1) To determine how NK cells are activated
and induce mouse pulmonary IRI (2) To determine how NK cells traffic to the lung during mouse pulmonary IRI
(3) To evaluate NK cell activation in human IRI. This work is innovative as these studies will make use of
advanced mouse surgical models and cutting-edge technologies such as next generation flow cytometry and
multiplex protein quantification to define a key innate immune response following lung injury. This research is
significant for veterans as it will identify pre-clinical and clinical therapies to use in veteran-health specific
diseases of acute respiratory distress syndrome, advanced lung disease, myocardial infarction, and stroke. This
work is novel as it will define a new role of NK cell receptors and stress ligands in IRI.

Public health relevance
Ischemia-reperfusion injury is the basic mechanism of tissue damage underlying many important diseases to veterans’ health. These include heart attack and stroke. In the lung, ischemia-reperfusion injury manifests as acute respiratory distress syndrome and primary graft dysfunction, two morbid and prevalent lung diseases without known therapies. Our veterans suffer disproportionately from end stage lung disease, making the improvement of lung transplant outcomes a vital mission. Thus, there is a critical need to develop new treatments. This proposal focuses on a novel mechanism of pulmonary ischemia-reperfusion injury in an understudied innate immune cell, the natural killer cell. Our data suggest a new and central role for natural killer cells that shifts our understanding of this disease process. This study employs cutting edge technologies to answer the fundamental questions of how NK cells cause this lung injury and how they traffic to the lung. These findings may lead to a better understanding of this process and novel therapeutic modalities targeting NK cells for veterans’ benefit.